Determining the role of lysine acetylation in alternative splicing regulation

The process of alternative splicing is regulated in part by RNA binding proteins (RBPs) that bind to
corresponding sequence elements in the gene transcript and influence the assembly of the spliceosome
components at adjacent splice sites. Recent studies highlight that many RBPs are modified at lysine side chains
by adding acetyl groups. Acetylation neutralizes the positive charge of the lysine side chain, which can i) disrupt
its capacity to interact with the negatively charged RNA backbone, ii) disrupt interactions with the π electron
cloud in nitrogenous bases, and iii) alter its ability to interact with other proteins. Acetylated RBPs have been
identified in many cancers and are linked to proteinopathy in neurodegenerative diseases. Similarly, spliced
variants have been identified in many gene transcripts related to neurodegenerative diseases and cancers.
Collectively, these data suggest a role for RBP acetylation in generating these disease-related spliced variants.
The treatment of such splicing-related diseases would be facilitated by a detailed mechanistic understanding of
how lysine acetylation regulates RBP properties and, in turn, alternative pre-mRNA splicing to generate spliced
variants. In this project, we propose to investigate the role of acetylation in alternative splicing regulation using
the RBP polypyrimidine tract binding protein 1 (PTBP1). PTBP1 is a well-characterized, multi-valent RBP
involved in alternative splicing regulation. PTBP1 is acetylated at several lysine residues in each of the four
RBDs and the N-terminal region that contains overlapping nuclear localization and export sequences. PTBP1
most often functions to repress the inclusion of regulated exons in spliced mRNA, and the mechanism of PTBP1-
mediated splicing regulation is well understood. We determined that PTBP1 acetylated lysine residues are highly
conserved and participate in RNA binding, protein-protein interactions, and sub-cellular localization. Thus, we
hypothesize that acetylation regulates the splicing activity of PTBP1. Our specific aims are to test this
hypothesis.
Aim1: Determine the role of PTBP1 RBD acetylation in its splicing activity
Aim2: Examine the role of acetylation in PTBP1 cellular localization and, in turn, splicing activity.
Aim3: Investigate signaling networks and transcriptome-wide targets of acetylated PTBP1
Our studies will answer fundamentally important questions about how acetylation modulates alternative splicing
activity to dictate mRNA isoforms, including disease-related splice variants. Importantly, our studies can
potentially unravel a novel mode of gene regulation at the level of mRNA splicing in eukaryotes. The proposed
studies will leverage experimental approaches established in the laboratory by previous undergraduate trainees
and provide new students (including those from backgrounds underrepresented in biomedical sciences) an
excellent opportunity to gain hands-on research experience in splicing chemical biology.

Public health relevance
Project Narrative Disease-related splice variants have been identified in many neurodegenerative diseases and cancers, underscoring the importance of alternative splicing regulation. We have discovered that RNA binding proteins, including PTBP1, that regulate alternative splicing in part, are post-translationally acetylated in disease tissues, including cancers. Learning how acetylation affects the activity of PTBP1 will enable a better understanding of how alternative splicing is regulated and may facilitate the development of novel therapeutics for treating splicing- related diseases.